Nanoparticle-coated macrophages for targeted disruption of YAP/TEAD interactions in breast cancer brain metastasis

Project Summary
Brain metastasis is prevalent among patients with metastatic breast cancer. Brain metastasis can emerge as
multi-focal, inoperable, and radiation-resistant lesions and remains a leading cause of death for breast cancer
patients. No effective therapies nor cures are currently available for breast cancer brain metastasis (BCBM).
Emerging evidence indicates that one of the rate-limiting steps in brain metastatic evolution is the overt
outgrowth of disseminated cancer cells through concurrent engagement of proliferative and survival pathways.
One key protein involved in these pathways is the Yes Associated Protein (YAP) transcriptional co-activator.
YAP is a target of the Hippo signaling cascade; its nuclear localization and association with the TEAD family
transcription factors activates downstream genes required for proliferation and resistance to apoptosis. Work
from Dr. Er (co-PI) and others have shown that YAP-TEAD association is necessary and sufficient for breast
cancer cells’ metastatic outgrowth in the brain downstream of cell adhesion signaling and
mechanotransduction, suggesting that targeting the YAP-TEAD interaction can potentially provide clinical
benefit for inhibiting metastatic outgrowth of disseminated cancer cells in the brain. Several TEAD auto-
palmitoylation inhibitors such as VT104 have been identified as a new class of potent YAP inhibitors that can
effectively inhibit cancer cell proliferation and tumor growth. However, one challenge in using these drugs for
brain metastasis treatment is their limited accumulation to the multi-focal metastatic lesions because of the
presence of multiple biological barriers such as the blood-brain and blood-tumor barriers. Currently existing
drug delivery approaches are not sufficiently effective in overcoming these barriers. Driven by this pressing
need, we propose to develop a macrophage-based technology (Macrophage Enabled brain Metastasis
Targeting, MEMT) for targeted delivery of YAP/TEAD-targeting drugs to multi-focal brain metastases. MEMT is
composed of macrophages carrying YAP inhibitor loaded nanoparticles (NPs) on their surface. Leveraging the
active migration of macrophages toward tumor, MEMT shuttles surface-anchored NPs to brain metastatic
lesions. We hypothesize that targeted disruption of the YAP-TEAD interaction in metastatic cells enabled by
MEMT could inhibit metastasis growth, offering a new approach for treating BCBM. Two independent aims
have been planned. In Aim 1, we will develop and optimize MEMT capable of delivering NPs to multi-focal
brain metastatic lesions. We will study the tissue- and cell-level distribution of MEMT to assess its capability in
delivering NPs to brain metastatic lesions in murine and humanized BCBM models. In Aim 2, by incorporating
a preclinically-tested YAP inhibitor into MEMT, we will evaluate MEMT’s efficacy in disrupting the YAP-TEAD
interaction and inhibiting brain metastasis progression in vivo. If successful, MEMT will revolutionize how
BCBM can be effectively targeted/treated and opens a new avenue for clinical research by unlocking
unrealized applications of YAP/TEAD-targeting drugs in treating brain metastases.

Public health relevance
PROJECT NARRATIVE Brain metastasis is a prevalent and deadly condition for patients with metastatic breast cancer currently with no effective pharmacological interventions or cures. Our recent work suggests that Yes Associated Protein (YAP) promotes breast cancer cells’ metastatic growth in the brain through its interaction with TEAD family transcription factors; the use of YAP inhibitors to disrupt YAP-TEAD association can be a promising therapeutic approach for brain metastasis, but its practical untility is hindered by the limited accumulation of these drugs to multi-focal metastatic lesions because of multiple biological barriers such as the blood-brain and blood-tumor-barriers. Here, we propose to engineer drug nanoparticle-coated macrophages to target “hard-to-reach” brain metastatic lesions for efficiently disrupting YAP-TEAD interactions in metastatic cells, which can potentially revolutionize how brain metastasis is targeted and pharmacologically treated.